Interdisciplinary NexGen TB research Advancement Center (IN-TRAC)

TEXAS BIOMED IN-TRAC OVERALL ABSTRACT
The Interdisciplinary NexGen TB Research Advancement Center (IN-TRAC) at Texas Biomedical Research
Institute (Texas Biomed) will attract the next generation of diverse researchers to the tuberculosis (TB) research
field, and develop them into independent researchers with multi-disciplinary skills and real-world experience of
clinical TB. The product of IN-TRAC will be researchers that choose to work on some of the most challenging
and relevant translational problems in TB, and that work across academic disciplines and within a framework of
highly collaborative research. This will be achieved through 6 interrelated Cores. Administrative Core: The
central hub of IN-TRAC management and oversight, with responsibility for administrative and scientific
leadership; coordinating communication between Cores, researchers and NIH/NIAID Program staff and
providing an organizational structure to optimize multidisciplinary collaborations and interactions between the
Cores and among a diverse cohort of IN-TRAC participants. Development Core: Oversight of all career
development programming and courses, tailoring the research and clinical experiences, both intern and
externships, to each individual IN-TRAC participant, and management of the IN-TRAC pilot grant program.
Biosafety & Biocontainment Core: Extending the required biosafety training to a personalized curriculum
including theoretical and hands-on biocontainment training, understanding the mechanical and regulatory
requirements of a BSL3/ABSL3, coaching on how to develop biosafety protocols, and working through risk
assessments from the perspective of a Biosafety Officer. Research Imaging Core: Providing theoretical and
hands-on training from single cell imaging (confocal microscopy, cytometry, live cell imaging, single cell RNAseq)
through to whole body imaging in mice (IVIS) and Non-human primates (NHP) (PET/CT) within large, fully
outfitted BSL3/ABSL3 facilities. Animal Model Core: Implementing a training program to introduce all IN-TRAC
participants to the regulatory requirements for working with rodents and NHPs, how to develop a robust
experimental protocol, how to write an IACUC protocol, and hands-on animal handling and experimental
procedures. Clinical Research & Patient Care Core: Introducing IN-TRAC participants to TB patient care at
the only free-standing TB hospital in the US (Texas Center of Infectious Diseases) that manages some of the
most challenging cases of TB nationally. Partnering with this will be a clinical research experience at the US-
Mexico border, to experience TB studies in under-served and under-resourced communities.

Public health relevance
PROJECT NARRATIVE The Interdisciplinary NexGen TB Research Advancement Center (IN-TRAC) at Texas Biomedical Research Institute will develop the next generation of TB researchers into independent scientists that work on some of the most challenging and relevant translational problems in the TB field. IN-TRAC will provide investigators with clinical and research knowledge combined with the soft skills necessary to move with confidence across multiple academic disciplines and within a framework of highly collaborative research.